Investigating the influence of human milk oligosaccharides on bacterial-immune dynamics in the gravid vaginal tract

Project Summary
The vaginal microbiota during pregnancy is an important reservoir for infant microbial seeding, but factors that
impact the composition are complex and largely unknown. Vaginal presence of neonatal pathogens, like group
B Streptococcus and extraintestinal pathogenic Escherichia coli, are associated with increased risk for adverse
infant outcomes. Current antibiotic-based therapeutics are not optimal given the rise in antibiotic resistant
bacterial strains, off-target microbial alterations, and potential long-lasting adverse outcomes for the neonate.
Thus, it is critical to identify factors that impact the vaginal microbiota during pregnancy to identify alternative
methods of limiting colonization and transmission of pathogens. Human milk oligosaccharides (HMOs) may be
one such factor that can impact the vaginal microenvironment during pregnancy. HMOs are the third most
abundant solid component in human breast milk, with over 100 unique HMOs identified thus far. HMOs provide
health benefits to breastfed infants, like promoting the growth of beneficial microbes and limiting adhesion and
invasion of pathogens in the gastrointestinal tract. HMOs are present in maternal circulation as early as
gestational week 10 and the presence of specific HMOs are correlated with composition of the vaginal microbiota.
This suggests there is a broader impact of HMOs in the mother that has not been explored. Our central
hypothesis is that HMOs within the vaginal microenvironment act on both the microbial community and on the
host to impact pathogen colonization and immune homeostasis. This hypothesis will be tested in the following
specific aims: 1) identify utilization of HMOs by vaginal bacteria and the impact of HMO supplementation on
vaginal microbial communities, and 2) investigate the potential of exogenous HMOs to confer a health-associated
state on the vaginal microenvironment. We will use a combination of vaginal swabs from pregnant human donors,
mini-bioreactor arrays, human vaginal epithelial organoids, and gravid humanized microbiota mice to explore the
interplay between HMOs, vaginal bacteria, and the host response during pregnancy. This proposal will provide
the applicant with training in organoids as a model system, animal models of pregnancy, and microbiome
analyses, while expanding on the applicant’s previous background in immunology. Training will take place at
Baylor College of Medicine under the mentorship of leading experts in the human microbiome and host-microbe
interactions. Ultimately, this proposal seeks to identify if HMOs impact the vaginal microenvironment during
pregnancy and assess their potential as a novel therapeutic alternative to antibiotics to limit pathogen
colonization during pregnancy.

Public health relevance
Project Narrative Transfer of beneficial microbes from mother to infant is a critical component of every pregnancy and important for limiting neonatal disease, but factors that influence the maternal vaginal microbial community are complex and largely unknown. Current methods of limiting transfer of pathogens, like group B Streptococcus, involve antibiotics, which come with off-target microbial alterations and potential adverse health outcomes for the infant. We seek to investigate if human milk oligosaccharides, one of the most abundant components naturally made in human breast milk, can impact the vaginal microenvironment during pregnancy and promote a health-associated vaginal microbiome, supporting the transfer of an optimal microbiome to the infant.